Training Program For Cancer Prevention and Control

1.0 PROJECT SUMMARY
The Ohio State University Comprehensive Cancer Center (OSUCCC) proposes to establish a postdoctoral
training program for cancer prevention and control that will prepare fellows to be impactful and independent
research scientists in academia, government or industry. This will be done by providing focused
transdisciplinary state-of-the-art research training. The overall goal of this training program is to reduce the risk
of cancer and improve the lives of cancer patients. The research areas for the postdoctoral fellows may focus
on carcinogenesis, behavior, cancer risk and survivorship. The training and research experience can be
laboratory-, clinic- or community-based. The transdisciplinary training includes a core curriculum, varied
research seminars, and emphasis on dual mentorship with biostatistical/bioinformatics advisors. The
participating faculty consist of the 2 program directors and 22 mentors, all of whom have track records for peer-
review funding, most participate or have participated in multi-investigator programmatic grants and are almost
all experienced senior leaders and hold the rank of Professor. The research areas and scientific disciplines
encompassed by the mentors included here are represented by their individual affiliations with four OSUCCC
Research Programs, while the faculty come from 6 OSU colleges. The OSUCCC and its research programs
have undergone the peer-reviewed Cancer Center Support Grant (CCSG) process, and received an
“Exceptional” descriptor (impact score of 10) for its state-of-the-art research, its research environment and the
ability to foster transdisciplinary research. Now, the OSUCCC is seeking to expand its training programs with a
specific focus on cancer prevention and control, one of our strategic priorities. While this is a new T32 training
program, the OSUCCC has a strong track record for postdoctoral training, such as a 39-year history of a T32
general oncology training program that has trained 154 postdoctoral fellows in basic and translational cancer
research by a cadre of outstanding NIH-funded participating faculty. While the OSU has numerous T32 training
programs, there are only four that have a cancer focus, and these have little to no cancer prevention activities.
Thus, there is little overlap with this newly proposed training program, which will have a large applicant pool
locally and nationally. This application details a specific recruitment, training and career development plans,
along with evaluation methods for the fellows and the overall program. There is strong institutional support and
senior leaders from the OSUCCC and several colleges have leadership roles in this application. This new
application seeks support for 2 trainees in year 1 and 3 trainees in years 2-5.

Public health relevance
PROJECT NARRATIVE Cancer prevention and control research remains a high NCI priority. The proposed training program is intended to contribute to the pipeline of young cancer control and prevention researchers who will become independent scientists.